The Role of Ribosomal Proteins in the P53-MDM2 Pathway

Project Summary The past half a decade has witnessed a great progress in the rapidly growing field of ribosomal stress (RS)-, or nucleolar stress (NuS)-RP-MDM2-p53 field. Growing evidence has demonstrated the biological importance of the RS-RP-MDM2-p53 pathway in development of human cancer and genetic diseases, such as 5q syndrome and Diamond Blackfan anemia (DBA). Also, more ribosomal proteins and their nucleolar or nucleoplasmic regulators have been identified in modifying this pathway. The crystal structure of the RPL11-MDM2 complex was just reported, which validated our previous study on the RPL11-MDM2 complex and also offered structural information for better understanding of the underlying mechanisms. Additional studies have shown that the RS responsive p53 activation also involves inhibition of MDMX, an MDM2 analog and partner. While trying to purify our previously proposed sub-ribosome complex that regulates this MDM2-p53 pathway, we identified Spin1 (Spindlin1) and RPL22 as two new regulators of this pathway. Spin 1 is a nucleolar protein that belongs to the tudar family, acts as a histone code “reader” to stimulate rRNA expression, and promotes genomic instability and cell transformation as a potential oncogenic protein. Interestingly, we showed that Spin1 binds to RPL5, preventing its association with MDM2 and consequently activating MDM2 and inactivating p53. Identification of RPL22 as another regulator is also remarkably significant because 1) knockout of its gene in mice is not lethal and non-essential for ribosome assembly and protein translation, and 2) it is highly mutated human cancers, such as colorectal and endometrial tumors, and/or down-regulated in lung cancer. Since RPL22 is the first RP whose mutations are highly associated with human cancer, our preliminary findings highly suggest that this ribosomal protein might be crucially important for preventing tumorigenesis via the RS- p53 pathway. More interestingly, RPL22 can bind to EBER-1, a short RNA encoded by Epstein-Bar virus (EBV) highly associated with nasopharyngeal and gastric cancers. Therefore, in light of growing evidence recently published in literature as well as our own published and preliminary studies, I hypothesize that the RS-RP- MDM2-p53 pathway is highly regulated by endogenous, such as Spin1, and exogenous, such as EBER-1, molecules, and this regulation is relevant to virus- or non-virus-pertinent cancer development. We will test this hypothesis by addressing four aims: 1) To further characterize the RS-RP-MDM2-p53 pathway biochemically; 2) To determine if dual defects of the MDM2-MDMX-p53 pathways rescues 5q-syndrome in mice; 3) To determine if Spin1 regulates the RPL5-MDM2 pathway; 4) To determine the role of RPL22 in regulation of the MDM2-p53 loop and cancer development. We will employ biochemical, biophysical, X-ray structural, molecular biological, cell biological, and genetic tools as well as recombinant proteins, cell line systems, xenograft, orthotopic tumor, and genetic mouse model systems. Completing these studies would offer new molecular insights into the RS-p53 pathway and its role in the development of genetic diseases and cancer.

Public health relevance
Project Narrative Aberrant alterations of the tumor suppressor p53-oncoprotein MDM2 pathway play a crucial role in the development of genetic diseases and cancer, but the underlying molecular mechanisms remain incompletely understood. Studies by others and us reveal that a group of ribosomal proteins can regulate this pathway and might be responsible for part of the alterations. This application is proposed to understand the role and regulation of these ribosomal proteins in the dependent development of genetic disease and cancer, and the underlying mechanisms, in hoping to ultimately identify novel molecules as anti-cancer drug targets.